Discovery of new phage defense systems in Vibrio cholerae

Abstract: Over a century ago, Felix d’ Herelle began using bacterial viruses which he termed “bacteriophages”
to treat bacterial infections. Such “phage therapy” has gained new interest due to the emergence of multi-drug
resistant bacterial pathogens. An advantage of phage therapy is the ability to lyse specific bacteria without
disrupting the host microbiota. Although phages can infect and lyse bacteria, bacteria have evolved a myriad of
molecular defense systems to protect against phage infection. This has led to the search and identification of a
plethora of novel phage defense mechanisms; however, there are still a vast number of phage defense
systems that have yet to be discovered and the molecular mechanism by which these systems mediate phage
defense is often not well understood. My research centers on the bacterial pathogen Vibrio cholerae as it is
intimately linked to phage predation both during environmental persistence and human infection. Moreover, V.
cholerae has been a catalyst in the discovery of multiple novel phage defense systems. Due to its intricate
relationship with phage, the central hypothesis of my thesis research is that V. cholerae encodes additional
novel phage defense systems. To identify these systems, I screened a V. cholerae cosmid genomic library in
Escherichia coli for segments of V. cholerae’s genome that protected E. coli from infection by T2 phage. I
identified one cosmid encoding 25 kB of DNA that provided E. coli protection against T2, T4, T5, and secΦ18
infection. Transposon and deletion mutagenesis on this cosmid revealed two distinct phage defense systems.
The first novel defense system involves two genes VC1767 and VC1766. Both genes are closely related to
Type IV Modification Dependent systems which are known to defend against phage infection by targeting
special modifications on the phage DNA. To uncover the mechanism of VC1767-66, I propose: 1) evolutionary
passage to determine whether phage DNA is being modified or if escape mutants arise, 2) purification of
VC1767 and VC1766 to determine their biochemical activity, and 3) quantification of phage genome replication
during infection to determine when protection occurs. The second novel defense involves three genes VC1764,
VC1763 and VC1762, which belong to a newly discovered but uncharacterized Zorya system. These genes
are hypothesized to be an abortive infection system that kills phage infected cells to protect the surrounding
population. To understand this system, I propose: 1) determine whether these three genes are sufficient to
protect against phage infection, 2) evaluate proton motive force disassociation to determine if this drives
defense, and 3) determine if this system exhibits abortive infection. Both systems will be further examined in V.
cholerae using mutagenesis and infection with V. cholerae phage. My studies will uncover the molecular
mechanisms by which these systems protect bacteria from phage infection, increasing our understanding of
the evolution and ecology of V. cholerae while highlighting important mechanisms by which bacteria can resist
phage therapy.

Public health relevance
Project Narrative: Bacteriophage defense systems have been pivotal in the discovery of genetic tools and vital for effective phage therapeutics. Within a few years there has been a vast amount of new phage defense systems discovered however most of the mechanisms of defense are not well understood. Our preliminary results will uncover the mechanism for two undescribed phage defense systems.